Neurocomputational mechanisms of serotonin, sustained stress, and mental effort allocation

Project Summary/Abstract
Human beings have a remarkable capacity for exerting cognitive control to achieve their goals, even though
performing such tasks can be stressful (e.g., getting into college, landing a job or promotion). Although the ability
to exert cognitive control to achieve goals in the face of ongoing stress is highly significant for determining one’s
productivity, health, and well-being, the neurocomputational mechanisms by which cognitive control is evaluated
are poorly understood. Recent research suggests that people consider the controllability of a sustained stressor
in deciding how to strategically allocate mental effort, yet how people perform this strategic adjustment is unclear.
Whereas substantial research has examined how acute stress (e.g., cold pressor) influences mental effort, less
is known about how the contingencies of sustained stress (e.g., ongoing controllable vs. uncontrollable shocks)
drive different strategies for mental effort allocation (e.g., attentional focus or response caution). This proposal
will investigate the serotonergic influence on neural and computational processes that underlie how individuals
exert mental effort in the face of sustained and uncontrollable stressors (shock). I will leverage our novel Stressor
Controllability and Cognitive Control (SCCC) model, psychopharmacology, and pharmaco-fMRI to identify these
neurocomputational mechanisms and test whether serotonin interacts with the aversiveness and controllability
of ongoing stressors to bias distinct effort strategies for control allocation. Aim 1 (K99) will use the SCCC model
to generate predictions for how sustained stressors guide different effort strategies (e.g., focus vs. caution) and
identify separate sub-processes that reflect the (1) aversiveness and (2) controllability of sustained stressors
during these decisions. Aim 2 (K99) will use a pharmacological probe (escitalopram) to test if controllability is a
key factor determining when and how SSRIs are effective in modulating strategic goal-directed adjustments in
mental effort allocation. Aim 3 (R00) will use pharmaco-fMRI to investigate to what extent distinct brain networks
(e.g., dorsal vs. ventral medial prefrontal cortex) underlie stressor controllability and cognitive control, and
localize serotonin influences in neural pathways. These Specific Aims support the applicant’s training goals
(computational modeling of stress/affect, psychopharmacology). The training plan includes various workshops,
courses, and guided readings to help the applicant gain the expertise to conduct trailblazing research on stress
and cognitive control as an independent investigator. The intellectual environment at Brown is rich and highly
interdisciplinary. The applicant will benefit from frequent interactions with world-renowned faculty with substantial
expertise in topics related to the proposed research (e.g., computational modeling of stress, affect, and cognitive
control). Understanding the computations, networks, and neurotransmitter systems through which sustained
stressors guide mental effort will inform how disrupted neural networks give rise to motivational impairments
(e.g., apathy, amotivation). Clarifying the role of serotonin in stressor controllability and mental effort is significant
and can help understand why and when people are vulnerable vs. resilient to stressors in psychiatric disorders.

Public health relevance
Project Narrative This project proposal uses computational modeling, psychopharmacology, and pharmaco-fMRI to investigate the neural and computational mechanisms by which people allocate mental effort when faced with sustained and uncontrollable stress. These data will provide the first direct and multi-modal examination of how people process the controllability of sustained stressors to guide dissociable strategies for allocating mental effort. Collectively, this research will provide an important foundation for understanding the computations, networks, and neurotransmitter systems that drive effortful thoughts and actions, and when and why they fail to do so (e.g., motivational impairments in depression, anxiety, OCD, Alzheimer’s).